Applied Methods for Improving Health Outcomes Across the Lifespan

The evolving complexity of healthcare delivery and research requires nurse scientists to integrate
advanced methods that span biological, behavioral, and environmental domains while harnessing
big data and evidence-based practices. In particular, participant-centered research that builds on
participant experience and real-world context is a transformative implementation research
paradigm by bridging the gap between science and practice through meaningful end-user
engagement to promote health for all. This T32 application requests five years of funding to
support a structured predoctoral research training program that prepares nurse scientists to lead
rigorous, innovative investigations aimed at improving health outcomes and service delivery
across the lifespan. The program offers a comprehensive curriculum and mentored research
experience grounded in four thematic cores: participant-centered study design, biological and
behavioral measurement, data science and analytics, and applied intervention strategies. These
methodological areas are critical for developing practical, scalable solutions that enhance care
effectiveness and inform public health practice. Our program faculty and mentors, drawn from the
Schools of Nursing, Medicine, and Public Health at Johns Hopkins University, bring extensive
expertise in interdisciplinary research, measurement science, and translational methods. Their
collective experience provides an exceptional foundation for training the next generation of nurse
scientists in advanced research methods and applied healthcare innovation. The two-year
training program will recruit four nurses at the predoctoral level each year. Training a new
generation of interdisciplinary nurse scientists with strong knowledge and skills in collaborative
research practices, measurement, and methodological approaches will further advance our ability
to address the complex nature of contemporary healthcare.

Public health relevance
For over 20 years, many studies have tried to improve health and reduce preventable illnesses and early deaths in the U.S. But challenges remain in achieving consistent care quality and timely access to effective health services for all individuals. We are proposing to train nurse scientists who can address these problems in new and effective ways which in turn will promote health for all.